8 WK COMPAR EFFICACY &SAFETY OF H 199/18 40MG &OMEPRAZOLE W/ EROS E

This is a multicenter, randomized, double-blind study comparing a new drug H199/18 with omeprazole for healing of erosive esophagitis.